Structural basis for differential regulation and selective inhibition of human CTP synthase 1

PROJECT SUMMARY
Cellular proliferation increases demand for ribonucleotide pools to provide precursors for increased RNA, DNA,
and membrane synthesis. This demand exceeds the capacity of uptake and salvage pathways, and must be
met by increased de novo biosynthesis. In particular, lymphocyte proliferation is dependent on increased
nucleotide levels, and targeting nucleotide biosynthesis pathways is the basis for a number of highly successful
immunosuppressive treatments. CTP Synthase (CTPS) is the key regulatory enzyme in pyrimidine nucleotide
biosynthesis. Humans have two CTPS isoforms encoded on separate genes, CTPS1 and CTPS2. While
CTPS1 expression is generally increased in proliferative tissues, little else is known about differential roles of
the two isoforms or how they are regulated. CTPS1 plays a critical role in the immune response, and loss of
function mutations in humans cause severe immunodeficiency. Loss of CTPS1 results in impaired T and B-cell
proliferation, but does not have deleterious effects in other human tissues, indicating unique dependence of the
immune response on CTPS1 function. Selective inhibition of CTPS1, therefore, is considered a potentially
powerful approach to immunosuppressive therapies with limited off-target effects. A number of inhibitors that
specifically target CTPS1 have recently been reported, but the mechanisms of inhibition remain unclear. Here,
we focus on the structural and functional characterization of CTPS1 and CTPS2 regulation by native allosteric
regulators and by selective small molecule inhibitors. This work will provide insight into the control of nucleotide
biosynthesis during cellular proliferation, and serve as the basis for design and targeted discovery of novel
compounds with potential for immunosuppressive therapies.

Public health relevance
PROJECT NARRATIVE The healthy human immune system responds to pathogens in the body by rapidly increasing the number of lymphocytes, specialized cells that can identify and attack the invaders. This proposal focuses on the enzyme CTP synthase, which controls production of a key molecular building block that is needed to increase lymphocyte numbers. By learning how CTP synthase is controlled and how it can be inhibited we will lay the groundwork for therapies that suppress the immune system, for example in the treatment of hyperactive immune response in autoimmune diseases, or to prevent the rejection of transplanted organs.